Genetic and Molecular Studies of Neurogenesis

The human CMS contains a diversity of neurons and glia that regulate movement, perception, cognition, and overall behavior. Understanding how neuronal diversity is generated is clinically relevant for learning how to manipulate neural stem cells to generate needed cell types on demand, for recognizing the primary defect in neurodegenerative diseases, nervous system cancers, or for understanding behavioral disorders. Drosophila and mammals share a high degree of conservation in the mechanisms regulating neurogenesis, so we are using Drosophila as a model system for understanding how neural diversity is generated. The generation of neuronal and glial diversity requires the production of the appropriate cell types at the right place (spatial patterning) and at the right time (temporal patterning). Disruption of either spatial or temporal patterning can lead to embryonic lethality or birth defects. While the mechanisms regulating spatial pattern formation are well studied, relatively little is known about how neurons and glia are generated at specific times during CMS development. We and others have shown that four transcription factors are sequentially expressed in embryonic neuroblasts (Hunchback, Kruppel, Pdm1/2, and Castor). We have shown that Hunchback and Kruppel are necessary and sufficient for specifying "temporal identity" in several neuroblast lineages;for example, hunchback mutants lack the first-born neurons whereas extended hunchback expression leads to a reiteration of first-born neurons at the expense of later-born neurons. Major questions that we will address in this grant proposal are:(1) What are the transcriptional targets of Hunchback in the CMS? (2) What is the function of the later genes in the series, Pdm1/2 and Cas? (3) What is the "timer" that regulates the sequential expression of these four factors? (4) Can we identify additional genes that regulate temporal identity? These questions are relatively difficult to address in mammals, but over the last two decades it has become clear that model organisms such as Drosophila can be used to identify molecules and mechanisms important for mammalian neurogenesis. Thus, we propose to continue our investigation of temporal patterning in the Drosophila CMS,with the goal of providing insight into the mechanisms regulating temporal patterning during mammalian neurogenesis.